Analysis of active genetic elements in germline and somatic cell lineages

Project Summary: Ten years ago, my laboratory and collaborators pioneered the field of "active genetics", in
which CRISPR-based genetic systems bypass the fundamental rules of traditional genetics. Briefly, a transgenic
cassette expresses the Cas9 endonuclease and a guide RNA (gRNA) that directs DNA cleavage precisely at the
site of its genomic insertion. In the germline of heterozygous carriers, the Cas9/gRNA complex cuts the opposing
homolog chromosome, and the cassette is copied onto the homologous site through efficient homology directed
repair (HDR). Spreading through populations in a super-Mendelian fashion, these “selfish” genetic entities, often
referred to as gene-drives, offer a variety of potential applications for combatting insect vector borne diseases,
crop pests, and insecticide resistance. Gene-drives can be used either to reduce insect numbers (suppression
drives) or to modify insect populations to render them harmless (modification drives). Gene-drives can also be
used to bias inheritance of a beneficial or favored allelic variant. For example, such allelic-drives can be used
to revert a common insecticide resistant allele of the voltage gated sodium ion channel back to wild-type
sensitivity in freely mating populations. These drive systems offer a new avenue to combat vector-borne diseases
such as malaria, or potentially to curtail agricultural damage and enhance food security. Active genetic systems
also can function in somatic cells of the body to copy gene cassettes or specific favored allelic variants from one
chromosome to its homolog. Such interhomolog somatic copying could potentially restore function of disease-
causing heterozygous mutant alleles using sequences copied from the intact chromosome.
My proposed research program will focus on developing new active genetic systems functioning in both
germline and somatic cell contexts. For example, we will develop and analyze the dynamics of transiently acting
self-eliminating allelic-drive systems to reverse insecticide resistance while leaving no transgenic imprint behind.
Studies will also include a new linked semi-drive system in which a driving gene cassette is inserted into an
intron close to the allelic editing site, which results in the gene cassette being co-driven at intermediate levels
along with the preferred allele. An important research area will be to understand mechanisms contributing to the
efficiency of gene-cassette copying including a requirement for two-sided homology flanking drive elements.
Another important arena of investigation will be to explore factors determining the respective efficiencies of Cas9-
and scarless Nickase-induced copying in somatic and germline lineages. We will also develop models in
Drosophila and human cells for correcting disease alleles by interhomolog repair, and tools to image DNA repair
components in situ. Such inquiries will address how distinct DNA repair programs elicited by Cas9 versus
Nickases result in alternative interhomolog conversion outcomes in differing developmental and cellular contexts.
These combined studies should provide mechanistic insights active genetic processes and offer impactful
applications for next-generation gene-drives and scarless genetic therapies.

Public health relevance
Project Narrative: My group has developed novel CRISPR-based gene-drive and allelic-drive systems that copy gene cassettes or favored allelic variants from their chromosome of origin to the homologous chromosome with high efficiency in germline and somatic cells. In this proposal, we will advance these game-changing tools to develop next-generation germline drive systems, which can be applied to block transmission of malarial parasites in mosquitos; and in somatic cells, we will dissect the mechanistic basis for the differential activities of Cas9 versus single-strand nicking derivatives (Nickases) to provide potential alternative gene therapy strategies that employ functional sequences on a homolog chromosome as a repair template to correct defective alleles on the mutated chromosome.